A First-in-class Topical Immunoregulatory Therapeutic for Psoriasis

A First-in-class Topical Immunoregulatory Therapeutic for Psoriasis
BioTherapeutics Inc (BTI) is an emerging biotech company that synergistically combines the power of
advanced computational modeling with translational experimentation to accelerate the development of novel
product candidates for precision immunology. An unmet clinical need for safer, more effective drugs for plaque
psoriasis remains as current therapies have limited efficacy and adverse side effects.
The Technology & Product. Psoriasis (PsO) is a global health concern that affects 125 million people
worldwide. PsO is presented as scaly and erythematous skin plaques in the scalp, elbows, knees, and lower
back, associated with severe itchiness and persistent rashes that have a significant detrimental impact on quality
of life. Despite advancements in treatments, an unmet clinical need remains for the development of novel
therapeutics against plaque psoriasis. This SBIR application aims to advance the development of a novel first-
in-class therapeutic that is being evaluated for the treatment of multiple autoimmune diseases as a well-tolerated,
topical therapeutic for the treatment of plaque psoriasis.
The Specific Aims for the SBIR Phase I application are to:
1. Evaluate the permeability and long-term stability of the novel topical drug product formulation.
We will further characterize the topical formulation developed by in vitro permeation testing and long-
term stability in preparation for the initiation of the clinical studies.
2. Compare the therapeutic efficacy of our product candidate to current approved PsO therapeutics
in a mouse model of psoriasis. We will use the imiquimod mouse model of psoriasis to evaluate disease
activity, histological lesions, plus local and systemic inflammation.
3. Determine the translational potential in human primary cells. We will use blood samples from
psoriasis patients to investigate the new candidate’s functional ability to induce immunoregulatory
changes in patients.
Expected successful outcomes: i) >10% permeation by IVPT; ii) >40% decrease in composite score on day 7
compared to other drugs; and iii) >40% decrease in Th17 differentiation in human primary cells.
Our long-term goal is to develop safer, more effective first-in-class immunoregulatory therapeutics for PsO with
a novel mechanism of action that address an unmet clinical need for a market exceeding $12 billion and growing
5% annually.

Public health relevance
Public Health Relevance Psoriasis is a chronic disease in which the body’s immune system causes skin cells to multiply too quickly and an important public health concern that affects 125 million people worldwide. This immunoregulatory therapeutic program builds on the successful development of a new class of drugs that have demonstrated excellent therapeutic activity a wide therapeutic margin with no dose-limiting toxicities. This SBIR Phase 1 application aims to develop a first-in-class topical skin therapeutic for plaque psoriasis towards filing a new IND and initiating human clinical testing in the next 12 months.